Harvard University Center for AIDS Research

PROJECT SUMMARY/ABSTRACT
Overall
This application proposes continued funding of the Harvard University Center for AIDS Research (HU CFAR).
HU CFAR is the umbrella organization for all AIDS research at Harvard, operating out of the Provost's Office.
It represents each of the Harvard affiliated schools as well as the affiliated hospitals, including Dana-Farber
Cancer Institute, Beth Israel Deaconess Medical Center, Boston Children's Hospital, Massachusetts General
Hospital, Brigham & Women's Hospital. In addition, it includes Fenway Health, extending its reach to additional
clinical populations and translational research sites outside Harvard. HU CFAR builds collaborations and
provides infrastructure support to coordinate and promote emerging opportunities in basic, clinical, behavioral,
translational and implementation HIV research. Research emphasis among investigators includes studies of
molecular virology, pathogenesis, host immune responses, epidemiology, treatment, vaccines prevention and
delivery. CFAR also oversees 4 Scientific Programs (Health Economics and Modeling; HIV Vaccines; HIV
Eradication) as well as 3 Scientific Working Groups (Adolescents and HIV, HIV and Aging; Reproductive
Health for HIV-Infected Populations). Five core facilities have also been identified for HU CFAR support:
Clinical Core, Biostatistics and Bioinformatics Core, Human Immune System Mouse, Core Advanced
Laboratory Technologies Core, Bio-Behavioral and Community Science Core. In addition, an Administrative
Core will provide strategic planning and fiscal oversight, and a Developmental and Mentoring Core will support
innovative pilot projects related to the goals of the scientific programs and scientific working groups, and
provide mentorship to develop the next generation of HIV researchers. Undertaking the following specific
aims, the HU CFAR will continue to evolve, to meet the needs of its members and the NIH AIDS research
priorities by promoting and facilitating collaborative, cross-disciplinary activities in AIDS research among CFAR
members, serving as a model for collaborative inter-institutional interactions at Harvard. Briefly, we propose to:
1. Facilitate and expand synergistic multidisciplinary collaborations among the diverse and highly
successful HU-affiliated HIV/AIDS researchers and their trainees
2. Promote new interactions and support innovative research initiatives capable of more effectively
addressing key HIV/AIDS related research questions aimed at bringing an end to the epidemic
3. Attract, engage, support and mentor the next generation of Early Career Investigators in HIV/AIDS
research

Public health relevance
PROJECT NARRATIVE Overall The HU CFAR is a comprehensive Center providing the infrastructure to integrate Harvard University's multidisciplinary AIDS-related clinical and basic research programs. This provides a unique platform to maximize the contribution to public health by Harvard's HIV/AIDS investigators.